Pain in PASC – The Role of Sleep Disturbances

PROJECT SUMMARY
Up to 80% of individuals infected with SARS-CoV-2 continue to experience persistent and debilitating
symptoms that extend >3 months into the post infection period, also called post-acute SARS-CoV-2 sequela
(PASC) or ‘long COVID’. Pain is among the most common symptoms remaining after 6 months following the
initial infection, along with sleep disturbance, fatigue, and cognitive impairment. The high prevalence rates of
post-viral complications are alarming. There is an urgent need to understand the disease mechanisms and
identify therapeutic targets. To date, factors such as the severity of the initial infection, medical co-
morbidities, or age do not sufficiently explain who develops PASC and who does not. We hypothesize that
sleep disturbance is a critical factor in the development and non-resolution of pain in PASC. Current
research strongly indicates that sleep supports maintenance of a pain-free state and optimal functioning of
central pain processing pathways. The proposed work will be the first to characterize the inter-relationship
between sleep disturbance and pain in PASC patients.
Twenty patients with PASC (PCR confirmed diagnosis of SARS-CoV-2), and 10 who had PCR confirmed
infection but did not develop PASC (PASC+ and PASC-), will be included in this research (>18 years of age,
50% females). A comprehensive pain testing and sleep assessment approach consisting of at-home and in-
laboratory subjective and objective monitoring methodologies will be used to address the following aims:
Aim 1 will characterize pain in PASC+ compared with PASC-. We will (a) monitor day-to-day
spontaneous/ongoing pain in the at-home environment, and (b) assess somatosensory deficits using
quantitative somatosensory testing (QST) during the in-hospital Clinical Research Center (CRC) visit. We will
evaluate the functional status of somatosensory modalities of touch, warmth, pressure, heat, and cold, as well
as the capacity of the central nervous system (CNS) to modulate pain.
Aim 2: will address the strength of association and directionality between indicators of sleep disturbance
and spontaneous pain/somatosensory functioning in PASC. Indicators of sleep disturbances will be
assessed by (a) day-to-day diary- and actigraphy-based monitoring of sleep in the at-home environment, and
(b) polysomnography (PSG) in the in-hospital environment to evaluate macro- and microstructural sleep
characteristics.
The proposed work will be the first study to explore the role of sleep disturbance in the persistence and
non-resolution of pain in PASC. Knowledge gained has the potential to influence therapeutic strategies
aimed at normalizing pain in PASC, including addressing sleep difficulties as a first intervention to prevent the
development of chronic pain in this patient population.

Public health relevance
PROJECT NARRATIVE At alarming rates, patients infected with the severe acute respiratory syndrome coronavirus 2 (SARS-CoV-2) continue to experience debilitating symptoms, with pain as one of the most common symptoms, for many months following the infection, also called post-acute sequelae of COVID-19 (PASC), or ‘long COVID’. For the first time, we will characterize pain and somatosensory deficits in PASC and hypothesize that sleep disturbance is a critical factor in the development and non-resolution of pain in PASC. Knowledge gained has the potential to lead to the design of interventions that will alleviate pain in PASC and prevent further development to chronicity.